The Effects of Accountable Care Organizations on Disparities in Childhood Asthma Care and Outcomes

ABSTRACT
Asthma is the most common chronic disease of childhood and causes more preventable
hospitalizations and lost school days than any other childhood disease. Children in lower-income, urban,
and racial/ethnic minority populations are more likely to have asthma, to have poorly controlled disease,
and to experience preventable morbidity. Multi-level interventions that address the complex array of
interrelated societal and environmental factors that contribute to these disparities are poorly supported
in traditional fee-for-service payment models. In contrast, accountable care organizations (ACOs) are
designed to support and sustain interventions that address social determinants of health as part of
medical care. A substantial and growing number children with asthma in higher-risk populations receive
care in ACOs, but their effect on asthma quality of care, outcomes and disparities is not known.
This study will be the first to address this critical gap in knowledge by taking advantage of a natural
experiment taking place in Massachusetts (MA), a state with high rates of childhood asthma: In 2018,
MA, launched 17 new Medicaid ACOs with varied organizational features (e.g., size; age mix). We will
use detailed state-level claims data to: 1) determine the association between implementation of the
ACOs and changes in childhood asthma quality indicators, health outcome for Medicaid-insured children
and 2) assess changes in socioeconomic and racial/ethnic disparities in these outcome measures
comparing children enrolled in Medicaid ACOs to matched commercially-insured children. We then turn
to understanding the influence of ACOs’ organizational features on change by: 3) using mixed-methods
to generate detailed characterizations of the ACOs’ organizational features and 4) test the association
between these features and childhood asthma quality indicators and outcomes. We will use innovative
methods of risk adjustment that take social risk factors into account and propensity matched difference-
in-difference analyses to account for factors other than ACO implementation that may affect outcomes.
This study will take place at a moment when the profound inequities in health and healthcare in the
U.S. are starkly illuminated by the COVID-19 pandemic. Socioeconomic and racial/ethnic disparities in
childhood asthma persist despite the existence of evidence-based treatments resulting from decades of
work and billions of dollars directed at improving asthma care. Structural changes in healthcare are
needed for equitable delivery of evidence-based asthma care, which should reduce or even eliminate
these long standing disparities. The ACO model moves healthcare payment and delivery in a direction
that could facilitate this change. This study will address major gaps in knowledge as to whether the large
investments being made in developing the ACO model may pay off for the millions of children at
increased risk for long-term poor health due to preventable consequences of asthma.

Public health relevance
NARRATIVE More than six million children in the U.S. have asthma, a chronic disease that disproportionately affects lower-income, urban and racial/ethnic minority populations. Accountable care organizations are designed to support interventions that address the social and medical complexity of childhood asthma in ways traditional healthcare models are not, but the effects of the accountable care ‘experiment’ on childhood asthma clinical care, outcomes, and disparities remain largely unknown.